Utah Children's Project

PROJECT SUMMARY / ABSTRACT
A comprehensive assessment of early exposures requires a multidimensional assessment of the exposome,
including community-level environmental factors (such as air pollution), chemical exposures (such as
endocrine disruptors), social factors (cultural and family context), and the genome and its responses to the
environment (inherited epigenome, genomic expression, and the proteome). The Utah Children’s Project
(UCP) has been the Utah site contributing to the ECHO Cohort consortium for 7 years. The UCP follows the
exposure and outcome status of up to 2 children and at least 1 biological parent in 493 family units as well as
enrolls couples planning pregnancy and pregnant people. In the UG3 Phase (the first two years),
preconception and pregnancy enrollments will continue during the development of the cohort-wide
preconception protocol in partnership with the other consortium sites. The UCP will also continue with retention
and follow-up of families previously enrolled. Exposure assessment during the preconception and pregnancy
periods is a specialized site focus area. In the UH3 Phase, preconception and pregnancy enrollments will
continue with particular emphasis on Utah families from underrepresented minority populations (eg, Native
Hawaiian or Other Pacific Islander, Hispanic), with a goal of up to 600 new enrollments with implementation of
all aspects of the ECHO 3.0 protocol while maintaining a historically high cohort retention. Research questions
to be investigated include (1) the relationship between subfertility, maternal metabolic status, fertility treatment,
breastfeeding, and asthma in offspring, (2) the relationship between indoor air quality and perinatal outcomes,
and (3) longitudinal preconception exposome mixtures and perinatal outcomes. A process-related aim is to re-
enroll and retain at least 95% of currently enrolled children throughout the UG3 Phase, and 90% through the
UH3 phase while implementing the ECHO 3.0 protocol with high fidelity and response rates.

Public health relevance
PROJECT NARRATIVE/RELEVANCE TO PUBLIC HEALTH High fidelity, longitudinal follow-up using the ECHO protocol will continue on an existing cohort of 881 children, 491 mothers, and 317 UCP fathers from 493 families in Utah while enrolling up to 600 couples planning pregnancy or pregnant people into the study. New and existing local and national data will be used to investigate the impact of potentially modifiable environmental exposures such as indoor air quality on perinatal and child health outcomes such as pregnancy complications and asthma. Data from multiple types of exposure assessment will be evaluated as mixtures to better understand the impact of environmental exposures as they are experienced rather than as individual exposures.